Adaptable and scalable electroporation for cellular therapy

Project Summary
Cellular therapies have demonstrated the potential to treat a variety of inherited and acquired
diseases, but the first generation of approved cell therapies rely on viral vectors for cellular
reprogramming. Viral vectors are recognized as a bottleneck in the development of these
therapies and other delivery methods, like electroporation, are being clinically investigated. To
address limitations in existing electroporation technology, CyteQuest is developing a simple,
scalable electroporation platform to optimize transfection parameters and deliver cargo
efficiently and reproducibly at high throughput. CyteQuest’s platform consists of a planar flow
chip with a thin slab geometry that ensures that cells are subject to a uniform electrical field for
reproducible electroporation. The flow cell geometry allows for seamless scaling to a high-
volume system for delivery at clinical scale. The key objectives of this proposal are to: (1)
demonstrate high-efficiency delivery of clinically relevant cargo including CRISPR/Cas9
ribonucleoprotein complexes to primary human T cells, and (2) construct a prototype large-
volume electroporation flow system compatible with the volumetric throughput required for
cellular therapy in a clinical setting. CyteQuest will demonstrate that the optimized
electroporation parameters of the small volume system can be used directly in the high-volume
system with less than 5% variation in the biomolecular delivery efficiency and cell viability. The
high-volume electroporation flow system can be manufactured in a process that is cost-effective
and robust. CyteQuest ultimately aims to use this novel platform in conjunction with
CRISPR/Cas9 technology as a therapeutic application for adoptive cell therapy.

Public health relevance
Project Narrative The delivery of biomolecules into cells is a critical step in biomedical applications, including cellular therapy, vaccination, protein production, drug discovery, and stem cell therapy. CyteQuest is developing a simple, scalable electroporation platform to optimize transfection parameters and deliver cargo efficiently and reproducibly in a high-volume GMP compatible format. CyteQuest envisions that this novel platform will be useful in conjunction with CRISPR/Cas9 or transposon technology for the advancement of clinical cellular therapy.